Novel roles of Fc gamma binding protein in colonic host-microbiota interactions

PROJECT SUMMARY/ABSTRACT
The Fc fragment of IgG binding protein (Fc gamma binding protein, FCGBP) is a prominent component of the
mucus layer that lines the epithelium of the large intestine. Reduced levels of FCGBP are present in the
structurally-weaken colon mucus layer that is characteristic of ulcerative colitis (UC). In addition, either low
expression or deficiency due to genetically mutated FCGBP is associated with lower disease-free survival of
patients with colorectal cancer (CRC). Normally, the abundance of FCGBP in the colon mucus layer is similar
to that of mucin 2 (MUC2), the major secreted mucin in the colon. However, unlike MUC2, the functions of
FCGBP are not well understood. In fact, a number of previously described functions of FCGBP, including the
IgG interaction from which the name derives, have been subsequently disputed. We posit that the abundance
of FCGBP in the barrier-protective colon mucus layer, coupled with the well-established association with
diseases of the colon, warrant an improved and definitive understanding of the functions of this protein in health
and disease. We have utilized mice with partial or complete loss of Fcgbp to begin to understand the functions
of Fcgbp at homeostasis and during inflammation. Our studies suggest previously unknown but essential
contributions to the structure of the colon mucus layer and to the composition of the mucus-associated
microbiota. Fcgbp deficiency also appears to trigger major compensatory pathways, which potentially underlie
the connection between low levels of FCGBP and susceptibility to colon inflammation and cancer. Therefore, in
this exploratory proposal, we will determine the contribution of Fcgbp to the overall glycosylation and terminal
sialylation of the colon mucus layer and determine how this affects the abundance of specific bacteria in the
mucus layer. In addition, we will explore immune pathways that are deployed to limit spontaneous inflammation
when expression of Fcgbp is suppressed and determine the possible connections to disease susceptibility. If
successful, our studies will define novel functions for Fcgbp in intestinal immune homeostasis and identify key
mechanisms whereby reduced Fcgbp impacts disease susceptibility in the large intestine.

Public health relevance
PROJECT NARRATIVE Despite being highly abundant in the colon mucus layer, the specific functions of the Fc fragment of IgG binding protein (FCGBP) in host-microbiota mutualism are not well understood. However, reduced expression of FCGBP have been associated with development and progression of ulcerative colitis and colorectal cancer. Building on provocative preliminary observations, this project will utilize rodent models to (1) investigate novel roles for Fcgbp in regulating host-microbiota spatial dynamics, and (2) determine whether and how reduced Fcgbp intersects with specific gut immune responses to enhance susceptibility to colonic inflammation.